Metabolic Control of Hair Follicle Stem Cell Homeostasis and Tumorigenesis

Abstract
In the last five years, we discovered a functional role for glycolytic metabolism in HFSC
homeostasis. We found that lactate dehydrogenase (Ldh) activity is essential for HFSC activation,
and that elevation of Ldh activity through blockade of pyruvate entry into mitochondria can
promote HFSC activation. Left unknown from this work is why and how, specifically, HFSCs’
activation is subject to regulation by Ldh activity and/or pyruvate oxidation in the mitochondria.
HFSCs are essential for new hair growth, contribute to wound healing, and are cancer cells of
origin for squamous cell carcinoma. Therefore, understanding how metabolism can regulate cell
fate in HFSCs has important implications. We have several hypotheses to explain how Ldh activity
and/or mitochondrial pyruvate oxidation leads to HFSC activation. First, we have found that Ldh
inhibition in tumors promotes glutamine anapleurosis, and it has been argued that glutaminolysis
is important for HFSC maintenance, so perhaps elevated glutaminolysis prevents HFSC
activation in Ldh-null stem cells. Second, lactate has been shown to act as a signaling molecule,
sometimes referred to as a lactormone. Third, it is possible that instead of lactate, an alternate
product of Ldh activity, L-2-hydroxyglutarate (L2HG), is the key metabolite promoting HFSC
activation; L2HG can impact the activity of a diverse class of enzymes, some of which modulate
epigenetic state and gene expression. Fourth, we have evidence to suggest that these same
regulatory mechanisms are affecting the decision of HFSCs to initiate and drive tumorigenesis,
so we will explore these hypotheses in an established cancer paradigm for squamous cell
carcinoma.

Public health relevance
Relevance We propose to understand how the metabolic state of hair follicle stem cells controls their quiescence and ability to initiate the hair cycle. We will use gain and loss of function approaches to target particular metabolic nodes to understand how they promote or inhibit stem cell activation or the ability of stem cells to initiate tumorigenesis. This work will not only uncover the role metabolic regulation plays in normal tissue, but also how this regulation can influence tumor initiation and wound healing.